Promoting patient portal use among Black women to lower barriers to breast cancer screening

Project Summary/Abstract
This K08 award will support the training and research experience needed for me to become an independent
clinician investigator in the development and evaluation of interventions to address cancer screening
inequities. I am an Assistant Professor of Medicine and primary care physician at the University of Washington.
The training goals set forth in this proposal will allow me to achieve my career goals to 1) develop expertise in
implementation science and health equity research, 2) lead research with communities to address inequities,
and 3) develop and evaluate interventions to address inequities. I have convened a mentorship team with
expertise in implementation science (Dr. Bryan Weiner), community-engaged research (Dr. Geetanjali Chander
and Dr. Rachel Issaka), and the design and evaluation of novel interventions (Dr. James Ralston) to help me to
achieve these goals.
Breast cancer mortality is significantly higher and screening rates are significantly lower among Black women
compared to White women. Patient portals offer multiple features such as online mammogram scheduling,
screening reminders, and secure messaging that can help lower barriers to breast cancer screening (BCS);
however, Black patients access the portal less often than White patients. Inequitable use in portals that may
contribute to differential BCS rates is an example of an intervention-generated inequity.
In this K08 proposal, we will design, implement, and test an intervention to promote portal use among Black
women to address this intervention-generated inequity and to help lower barriers to BCS. The specific aims of
the research are to 1) determine facilitators and barriers for portal use to facilitate BCS among Black women,
2) co-design an adaptive (multi-phase) intervention for portal access and uptake to facilitate BCS, and 3) pilot
and evaluate the adaptive (multi-phase) intervention among Black women due for BCS and not engaged in
portal use. The proposed work will inform an R01-level, multi-center randomized trial to test the intervention
and help me to become an independent, NIH-funded investigator focused on developing pragmatic, community
co-designed interventions to address cancer screening inequities.

Public health relevance
Project Narrative Patient portals increasingly are used to facilitate breast cancer screening (e.g., through online mammogram scheduling and screening reminders); yet Black patients use patient portals and receive breast cancer screening less often than White patients. The proposed study will determine facilitators and barriers for patient portal use to facilitate breast cancer screening among Black women; co-design with community members an outreach intervention to encourage and support patient portal use for breast cancer screening; and then implement and test this intervention in a large academic medical center. This research will result in the design and evaluation of a culturally tailored intervention that subsequently can be tested in a large, multi-center randomized trial.